3D Bioprinted Human Model of Duchenne Muscular Dystrophy (DMD) Cardiomyopathy to Study Disease Progression with Imposed Force and Precise Gene Editing

Duchenne muscular dystrophy (DMD) cardiomyopathy is ubiquitous, deadly, and results from mutations in the
dystrophin gene. Dystrophin is an essential component of cardiac mechanotransduction (MT) and distributes
mechanical stress across the sarcolemma. In DMD, the absence of dystrophin results in cardiomyocytes that
are vulnerable to contraction-induced damage, which accelerates disease progression. Our understanding of
the early progression of DMD cardiomyopathy is limited due to models that do not fully recapitulate human
disease, thus limiting development of effective therapies. Given the essential role of dystrophin in connecting the
contractile apparatus to the extracellular matrix (ECM) for MT, it is critical to augment DMD cardiomyopathy
models to include cell-ECM engagement with applied physiological force to recapitulate early changes at the
organ level necessary to test novel therapies. The human chambered muscle pump (hChaMP) can do just that.
The hChaMP is generated by 3D printing human induced pluripotent stem cells and bio-ink to yield a pump that
can be pressurized to impose progressive strain. The long-term goal is to determine mechanisms by which DMD
cardiomyopathy progresses to develop novel disease specific therapies to prevent cardiomyopathy. The overall
objective is to assess the role of altered MT and ECM dynamics in the absence of dystrophin on DMD
cardiomyopathy disease progression and to test dystrophin gene editing in a DMD hChaMP with volumetric
loading. The central hypothesis is that the loss of dystrophin leads to increased vulnerability to mechanical stress
resulting in early altered cardiac MT and ECM dynamics that promote disease progression and that early
dystrophin replacement will limit contraction-induced injury by restoring MT and ECM homeostasis and thereby
rescue DMD cardiomyopathy. Our central hypothesis will be tested in two specific aims: 1) To evaluate the
impact of altered MT on DMD cardiomyopathy disease progression using the hChaMP model system with
progressive volumetric loading; 2) To determine the impact of dystrophin restoration with DMD precise gene
editing on cardiac remodeling mechanisms dictating disease progression in DMD cardiomyopathy. In aim 1, we
will generate a DMD hChaMPs to assess the physiologic impact of increased volumetric pressure on the human
DMD phenotype early and later. In aim 2, we will introduce DMD precise gene editing to restore dystrophin both
early and late in DMD hChaMPs with volumetric loading and assess the physiologic and transcriptional changes.
At the successful completion of the proposed research, the expected outcomes of our study is the
characterization of early DMD cardiomyopathy progression with loading and the underlying molecular
mechanisms. The proposed research is innovative as it combines enabling technologies to develop a 3D
preclinical model of human DMD cardiomyopathy that mimics disease progression and correction with precise
gene editing. These findings will have a significant impact on human health by increasing our understanding of
disease progression and a strong basis for treating and preventing DMD cardiomyopathy.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because Duchenne muscular dystrophy (DMD) heart failure is ubiquitous and deadly, however there is a limited understanding of early disease progression due to the lack of relevant human models resulting in no current effective treatments to prevent or limit disease progression. This proposal is designed to allow Dr. Forum Kamdar, an early status investigator, pursue new research directions in cardiac tissue engineering and precise gene editing through the Stephen I. Katz Early Stage Investigator mechanism to develop a 3D DMD heart model using heart cells derived from DMD patient skin cells to understand how the disease progresses with application of force and if these changes can be stopped by correcting the mutation. This research is in tight alignment with NHLBI’s mission to promote the prevention and treatment of heart diseases and enhance the health of all individuals so that they can live longer and more fulfilling lives by identifying the early causes for DMD cardiomyopathy disease progression, test dystrophin gene editing, and to ultimately develop effective, disease-specific treatments to prevent DMD cardiomyopathy.